Comparative Biology of Tissue Repair, Regeneration and Aging

OVERALL PROJECT SUMMARY
Regeneration of damaged and lost tissues is limited in humans and other mammals. However, robust
regeneration is the norm for numerous diverse invertebrates and lower vertebrates. COBRE Phase I,
Comparative Biology of Tissue Repair, Regeneration and Aging, played a central role in establishing and
growing the Kathryn W. Davis Center for Regenerative Biology and Medicine (Davis Center) at the MDI
Biological Laboratory (MDIBL) and in dramatically improving the institution’s research environment. The Davis
Center was founded on the guiding principle that studying diverse animal models would lead to a detailed and
predictive understanding of the cellular and molecular mechanisms of tissue and organ regeneration, and an
understanding of why these processes are poorly active in most human tissues and of why they decline with
disease and aging. This in turn would lead to a rational foundation for development of regenerative medicine
therapies, particularly small molecule drug candidates capable of stimulating tissue regeneration and slowing
or reversing aging-induced degenerative changes in patients.
COBRE Phase I supported four early-career Project Leaders and one mid-career Project Leader. All
five Project Leaders graduated from Phase I with independent grant support. The average time for
graduation of the four early-career Project Leaders was 2.8 years. Phase I Project Leaders also achieved
multiple other successes including publication of significant peer-reviewed papers, creation of intellectual
property, receipt of foundation and R21 grants and significant peer recognition. Other noteworthy successes
include further development and patenting of MSI-1436, the only small molecule known to stimulate
regeneration of the adult mammalian heart following a heart attack, discovery of two small molecules
with potential to reverse chemotherapy-induced peripheral nerve damage, development of new disease
models and research tools, and formation of a growing IDeA program/Maine state government partnership that
allowed MDIBL to obtain $3M in voter-approved state bond funding to expand research infrastructure.
COBRE Phase II will continue to support the growth and development of the Davis Center in order to
establish a self-sustaining critical mass of investigators. Three new early-career scientists, Drs. Sam Beck,
James Godwin and Jarod Rollins, have been recruited as Phase II Project Leaders. Recruitment of a fourth
Davis Center faculty member is underway. Research programs of Phase II Project Leaders are highly
synergistic with and bring new scientific expertise to the Davis Center. Essential services and resources will
be provided to the Project Leaders and larger scientific community by continuation of the Comparative
Functional Genomics Core and Comparative Animal Models Core. COBRE Phase II will greatly enhance the
development of the Davis Center and MDIBL, which in turn will contribute to the continued enhancement of the
biomedical research environment in Maine.

Public health relevance
PROJECT NARRATIVE This Phase II COBRE grant will further expand the research program and create a critical mass of scientists in the Kathryn W. Davis Center for Regenerative Biology and Medicine at the MDI Biological Laboratory. Research in the Davis Center is focused uniquely on using diverse animal models to define the cellular and molecular mechanisms of endogenous tissue regeneration processes, and on translating that information into the development of new regenerative medicine therapies. COBRE Phase II builds on noteworthy successes of Phase I funding that included development of novel disease models, identification of lead drug candidates to treat heart attack and peripheral neuropathy and formation of a growing IDeA program/Maine state government partnership.